New precursors for diverse radical reactions enabled by potent photoreductants

PROJECT SUMMARY/ABSTRACT
Radical intermediates generated through chemoselective single electron reduction have broad utility in the
development of valuable synthetic transformations. As a consequence, photoredox catalysis, which induces
single election transfer with exceptional selectivity for radical pathways, has shown great promise as an
enabling technology in biomedical research. However, the design underpinning current photoredox catalysts
limits the accessible reduction potentials and excludes numerous abundant feedstocks. The selective
generation of radical intermediates from substrates inert towards conventional photoredox catalysis is a long-
standing challenge with no general solutions.
This proposal is based on the discovery that electrochemistry can generate new radical anion photocatalysts
that are exceptionally potent excited state reductants but retain the selectivity of typical photoredox catalysts.
We will study how these new catalysts can be exploited to develop radical coupling reactions infeasible with
modern synthetic tactics. The three specific aims of this research center on exploring distinct but interwoven
aspects of this new catalytic platform.
Aim 1. We are exploring the ability to generate and exploit the reactivity of aryl radicals from aryl chlorides
Aim 2. We are exploring the ability to engage carbonyl compounds in reductive radical coupling reactions
Aim 3. We are exploring operationally simple strategies to access radical anion photocatalysts
These methods address long-standing challenges in a fundamental class of organic reactions, reductions.
These new catalytic systems will offer an expanded and diversified pool of starting materials from which the
next generation of drugs and molecular probes will be discovered.

Public health relevance
Project Narrative The proposed research will develop a new catalytic strategy to selectively transform simple and inexpensive molecules into compounds of medicinal importance, such as pharmaceuticals. Ultimately, the proposed project will facilitate the development and large-scale preparation of new pharmaceuticals while simultaneously reducing the cost of life-changing medicines.